Connecting Circadian Clock Dynamics to Metabolism and Fitness

Project Summary
The Rust Lab seeks to understand the biophysical basis of circadian rhythms and how they are
connected to metabolism to support health and fitness. To do this, we are leveraging the power
of a bacterial model system where the circadian clock functions cell autonomously and the core
oscillator can be reconstituted in a test tube. We use a combination of live cell microscopy, protein
biochemistry, and deep sequencing approaches to interrogate this system. The ultimate goal of
this research program is to understand quantitatively the relationship between the circadian clock
and the external environment that is required for fitness and to be able to recreate an oscillatory
system that has these properties using purified components. During the award period, we plan to
build on our previous discoveries linking clock control of glycogen metabolism, protein solubility,
and DNA replication to understand how an appropriately timed metabolic switch allows cells to
tolerate cycling environments. To do this, we are creating new technologies that will enable new
assays. We will extend existing protein reconstitution systems using computer-controlled liquid
handling to create oscillators that mimic protein synthesis and degradation characteristic of
growing cells. We are developing live cell fluorescence reporters of glycogen metabolism. Finally,
we will unleash the power of deep scanning mutagenesis and high-throughput sequencing on
circadian clocks by creating saturating point mutant libraries of clock genes. We will determine
the oscillator phenotype of each mutation as well as its fitness in cycling environments. This will
provide an unprecedented view of the mutational plasticity of the circadian rhythm, the molecular
determinants of the rhythm, and the selective pressures on the clock.

Public health relevance
Narrative Modern lifestyles which rely on artificial lighting and irregular work schedules cause conflicts with our internal circadian rhythm which anticipates regular 24-hour cycles in behavior. We seek to understand how the circadian clock creates rhythms in metabolism that support health and fitness. By mapping how the circadian rhythm is altered by mutation we will define the relationship between the environment and the clock needed for fitness, ultimately revealing strategies to mitigate circadian disruption.